Enhanced Safety and Health Training for Western Mine Workers

Project Summary/Abstract The Colorado School of Mines (CSM) Energy, Mining and Construction Industry Safety Program (EMCIS) is a well-established training organization that was initially formed in 1999 as the CSM Mine Safety and Health Program. With mining still at its core, EMCIS operates its training center to enhance the quality and availability of health and safety training for Western mine workers. Goals include providing workers with relevant knowledge regarding hazards associated with working on mine sites and effective controls for reducing risk for injuries and illnesses. In addition, trainees will be continuously encouraged to be active participants in improving the health and safety conditions where they work. CSM proposes to offer a comprehensive approach to meet the safety and health training needs of the Western mining industry by providing a high quality, interactive training experience that targets several audiences: mine workers, trainers, safety and health professionals, mine management, mine rescue teams, and mining engineering and geology students. In addition, CSM’s training program will service underrepresented industry sectors such as contractors, consultants, suppliers and equipment manufacturers. Courses will be taught by highly qualified, professional instructors, who are technical experts as demonstrated by academic degrees, professional certifications and licenses, and experience. CSM will use the traditional classroom format, as well as an online delivery system, for these courses which will enhance the availability of these courses. The NORA sector that will be addressed by the EMCIS training center is the Mining Sector. Primary cross sectors of Hearing Loss Prevention, Musculoskeletal Disorders, Personal Protective Technology, Respiratory Diseases, Traumatic Injury, and Emergency Preparedness are addressed by being included as topics in various training courses offered to the mining industry.

Public health relevance
Project Narrative The CSM Energy, Mining and Construction Industry Safety program will provide a comprehensive approach that meets the safety and health training needs of the Western mining industry by providing a high quality, interactive training experience that targets several audiences from almost all the Western states including mine workers, trainers, safety and health professionals, mine management, contractors, consultants, and mining engineering and geology students. Exposing students to safety and health through the courses offered by CSM will reap future benefits when these students enter the workforce as they will bring with them the core values of a safety culture that have long lasting impacts to the mining industry. Overall, the CSM training courses will give mine workers knowledge regarding hazards associated with working on mine sites, as well as work practices and tools for reducing risk for injuries and illnesses.